UCI P30 Skin Center Systems Biology Core

Systems Biology refers to the integration into biology of ideas and methodologies from mathematics, engineering,
computer science, physics, and chemistry, with the goal of deriving greater understanding from data—especially
data that are complex, dynamic and/or high-dimensional. Systems biology makes frequent use of explicit,
quantitative models, and concerns itself both with how useful models can be derived from data and how models
can be used to generate hypotheses and drive the collection of new data.
Biomedical research is becoming increasingly reliant on systems biology approaches, yet researchers face many
challenges in acquiring the skills and insights to take full advantage of them. The goal of the Systems Biology
Core is to enable skin biology researchers to incorporate Systems Biology in their research, improving
productivity, enhancing rigor and reproducibility, and increasing research impact. This will be achieved by
providing services directed toward education, research assistance, and research integration. Strategies include
retreats, workshops, clinics, research development meetings, and project-specific consultation and collaboration.
Novel strategies include short-term embedding of “Skin Systems Biology Fellows” within the laboratories of skin
researchers, and proactive participation of core scientists in the re-analysis and integration of data generated by
the skin research community.
Core activities will leverage the expertise and resources of systems biology faculty with expertise in modeling
and data analysis; long-standing experience in teaching interdisciplinary science; and a track-record of
collaboration with skin biologists during the first grant period. It also leverages the infrastructure of a large
campus-wide center devoted to systems biology, the Center for Complex Biological Systems. Within the context
of the P30 center, the Systems Biology Core will act as a hub connecting the data-gathering effort of the
Multiomics and Imaging/Engineering Cores to new hypothesis generation and improved experimental design in
all areas of skin research.